Preclinical development of a synthetic lung surfactant dry powder aerosol for acute respiratory distress syndrome patients receiving different modes of ventilation support

Acute respiratory distress syndrome (ARDS) arising from direct lung injury is associated with a dysfunctional
lung surfactant system; however, large clinical trials of surfactant replacement therapy have been unsuccessful
in this population. The method employed for surfactant delivery in these unsuccessful trials was liquid bolus
instillation, which requires intubation, use of large liquid volumes (~500 ml) and subsequent mechanical
ventilation often late in the progression of ARDS. A successful dry powder aerosol synthetic lung surfactant
product would provide the advantages of early surfactant administration, potentially before the need for invasive
mechanical ventilation (IMV), rapid and high dose delivery to the alveolar region, and improved efficacy
compared with instillation based on preliminary animal model findings.
The goal of this study is the preclinical development of a synthetic lung surfactant dry powder aerosol product
(including delivery strategies, formulations and devices) for administration to adults experiencing ARDS or
hypoxemia from direct lung injury in a rapid, efficient and safe manner while receiving different modes of
ventilation support. Aerosol delivery strategies and devices will be developed and optimized for high efficiency
aerosol administration during high flow nasal cannula (HFNC) therapy, noninvasive positive pressure ventilation
(NPPV) and IMV. High efficiency aerosol administration will be enabled by a combination of a highly dispersible
spray-dried powder formulation, a new positive-pressure dry powder inhaler (DPI), and an excipient enhanced
growth (EEG) aerosol delivery strategy. Aerosolization performance and lung delivery efficiency will be
established and optimized using a concurrent approach of realistic in vitro experiments and computational fluid
dynamics (CFD) modeling. Animal experiments (in rats) will be implemented to determine appropriate levels of
the surfactant protein analog and assess in vivo efficacy of the lead synthetic surfactant dry powder formulation
in different models of direct lung injury. Specific aims of the project are as follows:
Specific Aim 1. Develop a synthetic surfactant dry powder aerosol formulation that can be easily dispersed into
a small particle aerosol with low air volume, exhibit hygroscopic growth, and enable stable product storage.
Specific Aim 2. Develop and optimize surfactant delivery strategies and devices that enable safe and efficient
aerosol administration to adults receiving HFNC, NPPV or IMV.
Specific Aim 3. Test the efficacy of the lead synthetic surfactant formulations administered with an animal-
version of the air-jet DPI using in vivo rat models of acute lung injury (ALI) mimicking bacterial infection, viral
infection, and ventilator-induced lung injury.
Outcomes and Impact. For patients receiving noninvasive ventilation, dry powder surfactant therapy is intended
to halt deteriorating lung function and prevent progression to IMV. If IMV is required, early dry powder surfactant
administration is intended to minimize further lung injury and enable more rapid and reliable extubation.

Public health relevance
Pulmonary surfactant is necessary for respiration and is severely depleted in acute respiratory distress syndrome (ARDS); however, surfactant replacement therapies have been generally unsuccessful in adults, most likely due to poor delivery to the alveolar region with high volume liquid instillation and administration late in ARDS development. In this project, a new synthetic lung surfactant powder product is developed (including delivery strategies, formulations and devices) that can be rapidly administered as an aerosol early and often in ARDS development during less invasive forms of ventilation support, such as high-flow nasal cannula therapy. Providing effective surfactant replacement therapy to the lungs during hypoxemia and ARDS is expected to minimize ongoing lung inflammation and injury, potentially avoid invasive mechanical ventilation (IMV), and in cases where IMV is necessary, significantly shorten the time to extubation.